BREAST AND OTHER CANCERS FOLLOWING X-RAYS FOR SCOLIOSIS

The main objective of this contract is to obtain managerial, technical, and clerical support for an expanded epidemiologic followup study of patients treated for scoliosis.